Adaptation to nighttime indoor heat exposure: the role of the built environment and behavioral factors

PROJECT SUMMARY/ABSTRACT
Heat waves are a growing public concern and a leading cause of climate-related morbidity and mortality in the
US. Eight out of 10 U.S. population live in urban areas. The combination of rising temperatures and urbanization
poses a significant risk for vulnerable urban populations due to the slow release of heat by urban heat islands
created by extreme summer temperatures. While adaptation planning for heat waves during the day has been
developed and implemented at the city-wide and governmental levels, heat adaptation behaviors in individual
households are less understood, particularly during nighttime hours. Although prior studies have identified
several individual factors associated with heat adaptation, the role of nighttime indoor heat exposure as an
external hazard has not been examined. Moreover, the contribution of the built environment on heat exposure
and individual adaptation behavior has not been fully evaluated although the build environment play a role in
residential household. To fill these gaps, we will examine the combined effects of individual factors, built
environment, and nighttime indoor heat exposure on heat adaptation behavior using the Protective Action
Decision Model. The long-term goal of this study is to reduce heat exposure risks and increase resilience to
climate change for vulnerable urban populations. Our aims are to establish a community advisory board and
examine the effects of indoor home heat exposure, individual attribute, and built environmental factors on heat
adaptation behavior. The study results will be disseminated to community leaders and residents. We expect that
disseminating our findings regarding the drivers and barriers of heat adaptation behavior helps individuals living
in underserved urban communities take the necessary steps to reduce their potential health risks associated
with nighttime heat exposure. We believe that the results of this study can provide an affordable and practical
adaptation strategies for those affected by heat exposure during nighttime. This proposed exploratory study is
directly responsive to the National Institute of Environmental Health Science Strategic Goal 2: Promoting
Translation- Data to Knowledge to Action: Emerging Environmental Health Issues (Climate Impacts on Health
and Preparation for Future Threats) and has the potential to reduce heat exposure risks and increase resilience
to climate change for vulnerable urban populations.

Public health relevance
Narrative The exacerbation of rising temperatures and urbanization poses an increased risk to vulnerable urban populations from heat exposure at night, as urban heat islands release heat slowly during summer nighttime. Although adaptation planning for high temperatures during the day has been developed and implemented at the city-wide or governmental levels, heat adaptation behaviors in individual households are less understood, particularly during nighttime hours. To gain insight into the combined effects of individual behaviors, built environment, and nighttime heat exposure on heat adaptation behavior in residential houses, we propose to (1) establish a Community Advisory Board, comprising local residents and academic researchers and (2) examine the collective impact of indoor home heat exposure, individual attributes, and built environment factors on individual-level heat adaptation behavior and provide guidance on effective heat adaptation strategies to community leaders and vulnerable residents.